Metabolic Impact and Mechanism of Enhanced Mitochondrial Calcium Uptake in Mitochondrial Cardiomyopathies

PROJECT SUMMARY
Diseases that arise from mutations in components of mitochondrial oxidative phosphorylation can be
devastating, as mitochondria are crucial for energy synthesis. These diseases occur predominantly in infants
and children, with a prevalence of 1 in 5000. Though virtually any organ can be affected, the heart is frequently
involved, because cardiac function has such high energy requirements. These mitochondrial
cardiomyopathies have a particularly grim prognosis, with mortality rates increased nearly three-fold
compared to children without cardiac involvement, and no specific therapies available. In linking cardiac
function to mitochondrial metabolism, calcium signaling may be central to the pathological process. Calcium
influx into the mitochondria can potently stimulate ATP synthesis. In the initial period of this application, we
identified a regulatory mechanism by which dysfunction within Complex I of the electron transport chain
causes a compensatory increase in activity of the mitochondrial calcium uniporter channel, preserving ATP
synthesis. During normal physiology, Complex I promotes uniporter degradation via an interaction with the
uniporter, a mechanism we term Complex I-induced protein turnover (CLIPT). During Complex I dysfunction,
interaction with the uniporter is inhibited, preventing degradation and leading to a build-up in functional
channels. This mechanism is widespread and was seen in fruit flies, mice, and humans. Moreover, while
inhibiting the uniporter led to early demise in Complex I-deficient animals, enhancing uniporter stability
rescued survival and function. In this project period, we propose the following three aims to further study this
pathway and determine whether it can be exploited for potential therapeutic benefit. We focus on
mitochondrial one-carbon (1C) metabolism, a producer of mitochondrial antioxidant species (NAPDH),
because this pathway is substantially upregulated in mitochondrial cardiomyopathies. In the first aim, we will
examine if adenine dinucleotides (NAD+/NADP+) regulate the uniporter, and if calcium regulates critical 1C
metabolism enzymes. In the second aim, we will establish whether uniporter activity in mitochondrial
cardiomyopathies extends beyond ATP synthesis to NADPH biology, affecting redox balance and one-carbon
metabolism. In the third aim, we will test whether manipulation of the portion of the uniporter that interacts
with Complex I, the uniporter N-terminal domain (NTD), can be exploited in mouse models as a potential
therapy for mitochondrial cardiomyopathies.

Public health relevance
PROJECT NARRATIVE Mitochondria provide the fuel for cellular activities, and diseases caused by mutations in their components represent a common inborn error of metabolism in children. Cardiac involvement in these disorders portends poorer outcomes, with a nearly threefold increase in mortality. In this proposal, we propose to study a novel regulatory pathway, involving enhanced influx of calcium into cardiac mitochondria, which may provide a new target for treating heart failure in these devastating diseases.